Clinical Core (Core C)

Modified Project Summary/Abstract Section

Situated in the Deep South, with prominent footing in rural communities in Alabama and adjacent states, the UAB CFAR Clinical Core is uniquely positioned to support scientific inquiries at the interface of prevention and treatment, in clinic and community settings. The Clinical Core mission is to provide ready access to integrated, comprehensive clinical research services to advance HIV prevention and treatment science and hasten an end to HIV. In the next funding cycle, the Core aims to achieve the following:
1. Increase productivity through computerized database and informatics services
2. Afford access to a comprehensive specimen repository
3. Provide study coordination services for successful implementation of prospective observational and interventional studies
4. Ensure research rigor through comprehensive biostatistics and epidemiology
The Clinical Core has been a cornerstone of the CFAR since its inception in 1988, with the UAB 1917 HIV Clinic (1917 Clinic) as one focal point with ~3,500 PWH and clients receiving PrEP services. Additionally, in the current funding cycle, Core services have meaningfully expanded to cultivate unique research platforms via the Alabama Quality Management Group (AQMG) that includes nine Ryan White clinics statewide providing care for over 6,800 PWH and 1,000 PrEP clients. The pursuit of improving clinical outcomes for populations impacted by the HIV epidemic has been the impetus for identifying clinically relevant questions, scientific discovery and scholarship that has fed back to the 1917 Clinic and others to enhance service delivery and treatment outcomes for PWH, with broad impact regionally. In the current funding period, the Clinical Core generated 680 analysis ready datasets, processed 124,000 specimen vials, and captured 8,000 patient reported outcomes (PROs) via assessments at the point of care, while supporting 70 extramural grant applications and >300 peer-reviewed manuscripts. A noteworthy milestone, the Clinical Core supported 7 early-stage investigators (ESI) from UAB and 4 ESI from other CFARs during the last funding period, who were collectively awarded 18 grants (including 14 K and 4 first-time R01s). Clinical Core innovations include expansion of collection of PROs to AQMG sites, roll out of ready-access “data bundles” with clinical data and linkage to biorepository specimens, and a new registry of HIV-negative people approached during HIV testing and consented to engage in research.
In summary, the Clinical Core plays a pivotal role enhancing intra- and inter-CFAR collaborations, providing vital research support, and leveraging synergies with other research Centers across the university – roles that will continue into the next funding cycle as the Core achieves its aims.